Interferon Beta Initiated Development of Immunogenic T1 B cells in Lupus

Systemic lupus erythematosus (SLE) is a chronic debilitating disease that is characterized by high titers of
autoantibodies with specificity for nuclear autoantigens. It is considered to arise from interactions between
underlying genetic susceptibility and environmental factors, with different combinations resulting in inter-
individual variations in disease manifestations and therapeutic responsiveness. Directed therapeutic targeting
of specific pathways has not proven effective, which suggests that the current understanding of pathogenesis
is incomplete. The goal of the proposed project is to test the hypothesis that the survival of immature
autoreactive B cells, the preferential development of antinuclear autoreactive B cells and the status of mature
autoreactive B cells (immunocompetent vs. anergic/tolerogenic) is decided during the transitional stage 1 (T1)
of development and requires constitutive T1 B cell expression of interferon β (IFNβ).
This paradigm shifting hypothesis is based on data generated using a combination of mixed-bone marrow
chimeras, flow cytometry with tetramer or idiotype antibody selection, and high-throughput single-cell analysis
to interrogate type I interferon (IFN) networks in B cell from patients with SLE and lupus-prone BXD2 mice. The
data suggest that the currently known molecular and cellular aberrations are preceded by a single primary
pathogenic event, i.e., production of IFNβ by T1 B cells. The data suggest that the survival of the very early T1
cells is dependent on endogenous expression of IFNβ. This subset of T1 B cells express endogenous IFNβ,
which leads to their development into T1 B cells that produce IFNα. The ability of T1 B cells to escape negative
B-cell receptor (BCR)-mediated selection is dictated by the type I IFN-determined responsiveness of this T1
subset to BCR-mediated signaling in combination with stimulation of TLR signaling (TLR7 or TLR9) by
apoptotic debris. This preferentially permits escape of nucleic antigen-autoreactive B cells. We have further
identified that the T1 B cell compartment contains distinct subsets of cells. As these included subsets with
transcriptional profiles that parallel the phenotypes of mature and anergic suppressive regulatory (Breg) cells
and their immunogenic counterparts that predominate in SLE, our new data suggest that this phenotypic switch
in the mature B cells is imprinted during the T1 stage. These data also suggest that development of type I IFN
network associated T1 B cells in BXD2 mice is associated with type I IFN-inducing transcription factors (IRF3
and IRF7) whereas induction of the Foxp3+ regulatory T1 B cells is associated with transcription factor, ID3.
Notably, these data not only suggest suppression of precursors of T1-Breg is a novel pathogenic
framework in SLE but also provide the tool, i.e., the gene expression signatures in sorted transitional B cells,
that enable its analysis. We will test the critical elements of our overall hypothesis through three Specific Aims
that will: (1) Distinguish the roles of the constitutive IFNβ signaling and the microenvironmental signals in
driving the development of T1 B cells; (2) Identify if the initial T1 B cell transcriptional imprinting is maintained
at the T2/MZP-MZ-FO stage of development; and (3) Determine if T1 B-cell endogenous IFNβ promotes a type
I IFN network that suppresses the precursors of regulatory B cells at the T1 stage in SLE patients. The
scientific premises of the proposed work include the parallels between transcriptional profiles in the T1 B cells
and mature B cells and the segregation of type I IFN associated vs Breg associated transcriptional profiles in
the T1 B cells. We have acquired reporter mouse strains for IFNβ, IL-10, Foxp3 and Id3 to interrogate discreet
developmental stages within and derived from transitional T1 B subsets.
The information gained will have a broad-based impact on the field and improve the care of VA patients
with SLE by identifying strategies to improve the efficacy of targeted biologic therapies together with non-
invasive precision medicine guided-approaches.

Public health relevance
Systemic lupus erythematosus (SLE) is a devastating autoimmune disease that is characterized by high autoantibody titers and elevated type I interferon (IFN) responses. Our use of powerful new techniques, including single cell gene expression analysis, has generated data indicating that intrinsically elevated IFNβ production by early immature B cells imprints altered responses to IFNα signaling on the maturing B cells. This both promotes escape of autoreactive cells from normal deletion process and shifts development of suppressive regulatory B cells toward a proinflammatory phenotype. This paradigm shifting hypothesis will be tested using advanced in vivo and in vitro techniques to distinguish the roles of intrinsic B cell defects and environmental signals; test the proposed imprinting of the maturing B cells and its effects on tolerance induction and maintenance; and test if the intrinsic or imprinted B cell defects correspond to disease activity and therapeutic responsiveness in SLE patients at the BVAMC.